Global and Local Genetic Ancestry Impacts on Differential Outcome of Systemic Lupus Erythematosus and Multiple Sclerosis

PROJECT SUMMARY
The objective of our study is to identify ancestry related genetic variants contributing to differential risk of
manifestations of both systemic lupus erythematosus (SLE) and multiple sclerosis (MS) in subjects of different
genetic ancestries. SLE is an autoimmune disease with heterogenous features characterized by autoantibody
formation and MS is an immune-mediated, demyelinating disorder. We will investigate the association between
genetic ancestry and clinical outcomes of SLE and MS that are known to differ in prevalence and severity between
SLE or MS patients of different races. Outcomes for SLE will include age of onset, autoantibody status, and lupus
nephritis. Outcomes for MS will include age of onset, cognitive impairment, and MS severity score. We will study
~4,000 SLE and MS cases. In Aim 1, we will use ~2,000 SLE cases from the UCSF Lupus Genetics Study and
California Lupus Epidemiology Study (CLUES) and ~2,000 MS cases from the Kaiser Permanente Northern
California (KPNC) MS Research Program and Kaiser Permanente Southern California (KPSC) MS Sunshine
Study to investigate the association of global ancestry and the outcomes of interest for SLE and MS. In Aim 2,
we will investigate the association of local ancestry genome-wide and of candidate SLE and MS SNPs with the
same clinical outcomes. In Aim 3, we will test for the association between both active and passive tobacco
smoking and respective outcomes as well as test for gene-environment interaction between active and passive
smoking and global and local ancestry. By establishing whether global and local genetic ancestry contribute to
clinical heterogeneity and severity of SLE and MS, or if there are differences in gene-environment interaction
with environmental exposures such as smoking, we might be able to target patients based on risk of disease
outcomes by evaluating genetic ancestry of admixed patients. It might also be possible to predict disease
manifestations and allow for early intervention and improved targeted treatment strategies limiting severity of
disease and improving quality of life. This research project and associated training plan were developed in
collaboration with my sponsor, Dr. Lisa Barcellos, co-sponsors, Drs. Lindsey Criswell and Laura Fejerman, and
collaborators, Drs. Andres Cardenas and Priya Moorjani. The training plan emphasizes scientific productivity
and building a strong knowledge of epidemiologic, biostatistical, and computational methods, as well as
immunology and SLE and MS autoimmune disease processes. As a student at UC Berkeley, I am well supported
by an institution that values rigorous scientific research and have access to many research and professional
resources. Ultimately, the proposed research and achievement of the goals outlined in the training plan will allow
me to become a multidisciplinary, independent investigator and facilitate my transition into a post-doctoral
position and early-investigator faculty or research position.

Public health relevance
PROJECT NARRATIVE Autoimmune diseases, including systemic lupus erythematosus (SLE) and multiple sclerosis (MS) have debilitating clinical features which vary between different ancestral populations. Since disease manifestations may differ by genetic ancestry, understanding the effect of genetic ancestry and interactions with active and passive tobacco smoking exposure on clinical outcomes of SLE and MS is an important step towards predicting disease outcomes and allowing for early intervention and treatment for different ancestral populations.